Statistical Methods for Inferring Gene-Phenotype Associations Using Omic Data from Gene Knockout and Human Phenotype Studies

Project Summary
The phase 1 of the Molecular Phenotypes of Null Alleles in Cells (MorPhiC) consortium will produce a catalog of
molecular and cellular phenotypes for null alleles of ~1000 human genes using in vitro cellular systems. These
rich resources will allow us to study the gene functions in several multicellular systems that often model early
human development. The impact of a gene knockout on complex human phenotypes can be highly dependent
on the corresponding cell type, cell stage, and tissue microenvironment. Therefore, to generalize the insights
from MorPhiC studies to in vivo settings, we need to harmonize MorPhiC resources and the molecular/cellular
phenotypes of appropriate cell types or tissues, by a flexible and robust computational framework. We aim to
achieve this goal by two complementary approaches. First, we will develop a dynamic gene regulatory network
named moDAG: multi-omic Directed Acyclic Graph. MoDAG combines multi-omic data from MorPhiC and other
studies and the state-of-the-art statistical methods to estimate a gene-regulatory network. MoDAG models cell
types characterized by genome-wide epigenetic or gene expression data. It also accounts for signals from tissue
microenvironment by modeling a set of signaling proteins. MoDAG can be used to predict the effect of gene
knock out in the in vitro cellular systems, and thus help prioritize the genes to be targeted in future MorPhiC
studies. Second, we propose a biologically informed deep learning method named as SDAN: Supervised Deep
learning with gene Annotation. SDAN combines molecular phenotype of gene knockout with gene annotation to
identify gene sets associated with gene knock out. Gene sets provide more robust characterization of gene
knockout than individual genes and thus are more generalizable to different cell types or tissues. The gene
annotation used by SDAN is gene-gene interaction network that can be modified according to relevant cell types
or tissues. Finally, we apply these two methods to predict the phenotypic outcomes of gene knockouts and
assess the association between gene knockouts and human phenotypes. Our computational framework bridges
MorPhiC’s resource with accumulating omic data in various human cell types and tissues and provide effective
solutions to generate new insights or hypothesis for future studies.

Public health relevance
Project Narrative MorPhiC consortium will deliver rich resources of molecular and cellular phenotypes before and after gene knockout using in vitro cellular systems. We will develop statistical methods to combine MorPhiC resources and omic data in human phenotype studies to infer gene functions in diverse settings and identify potential causal genes of human phenotypes. Our methods pave the way to use MorPhiC resources to study the impact of gene loss on complex phenotypes.